Next generation functional genomics of hematology traits

PROJECT SUMMARY
The over-arching goal of this project is to address several major challenges to biologic interpretation, functional
validation, and clinical translation of genetic association findings for quantitative red blood cell traits and non-
malignant blood cell disorders in the post-genomic era. We seek to significantly advance the work that we have
done over the current funding cycle to define how genetic variants can impact erythrocyte (red blood cell) traits
and to functionally define mechanisms through which these variants act. In Aim 1, we will apply state-of-the-art
statistical genomic and computational tools to extremely large human multi-ethnic datasets containing nearly 1
million individuals with red blood cell traits (hemoglobin, hematocrit, RBC count, MCV, MCH, MCHC, red cell
distribution width or RDW) and whole genome sequence (WGS) or exome sequence data (the NHLBI TOPMed
WGS project, UK Biobank, All of Us, and deCODE) to provide updated analysis, discovery, and interpretation of
results, particularly for rare and ancestry-specific genetic variants associated with red blood cell counts and
indices. We will include analysis of genomic regions missed by prior GWAS efforts such as large structural
variants, variants on the X chromosome, and mitochondrial DNA copy number. Validation of new red blood cell
phenotype-associated genomic loci and genetic variants will occur through imputation and replication in
independent data sets using TOPMed WGS as imputation reference panel. We will also continue to provide
functional annotation, fine-mapping, and prioritization for new and existing red blood cell trait-associated variants
and genes, with an emphasis on utilization of newer multi-omic data sets derived from African and Hispanic
individuals that are becoming available through the TOPMed project. In Aim 2, we will assess the contribution
of polygenic variation (across the entire allele frequency spectrum) as phenotypic modifiers of red cell disorders
such as anemia and erythrocytosis, phenotypic expressivity of high-impact Mendelian red cell disorders, and the
contribution of red cell polygenicity to other complex disorders such as venous thromboembolic disease, stroke,
and COVID-19 disease severity. In Aim 3, building on previous integrative genomic and functional analyses to
define relevant hematopoietic cell states and mechanisms, we will develop comprehensive maps of how genetic
variation associated with red blood cell traits can impact human hematopoiesis using emerging single-cell
epigenomic chromatin accessibility and RNA sequencing atlases to provide predictive assessments of regulatory
non-coding variation and function. We will disseminate all genomic, annotation, and functional information
derived from Aims 1, 2, and 3 to ensure knowledge dissemination to the clinical and scientific community, for
discovery, fine-mapping, and investigation of causal genes that underlie red blood cell traits and hematological
disorders.

Public health relevance
PROJECT NARRATIVE This project will lead to improved insight into the genetic basis of hematologic traits and red blood cell disorders. Finding the risk factors and causes of these disorders or traits will lead to new insights into why they occur, and, potentially, how they can be treated. Our project will create a renewable resource for the scientific community for research into human red blood cell production and how this goes awry in disease.